Deciphering the genetic regulation of bacterial heterogeneity in response to antibiotic stress using single-cell transcriptomics

Abstract
Bacteria utilize diverse stress responses to survive and adapt under stress conditions. These responses
contribute to the development of antibiotic resistance (mutation acquisition) and bacterial persistence (transient
phenotypic adaptation), posing a significant threat to cause antibiotic treatment failure. Currently, most efforts to
understand bacterial responses to stress primarily focus on characterizing entire populations, assuming uniform
stress-response pathways across all cells. However, using a high throughput bacterial single-cell RNA
sequencing (scRNA-seq) technology I developed over the past three years, we discovered that heterogeneous
subpopulations of bacteria are prevalent during antibiotic treatment, including unique subpopulations enriched
with antibiotic-resistant and persistent cells. For the first time, we can map the full picture of genetic factors
driving heterogeneity and elucidate the underlying molecular mechanisms. The long-term goal of my research
program is to comprehensively characterize bacterial heterogeneity in response to antibiotic stress and identify
the underlying genetic regulators that can be potentially used as drug targets to prevent the development of
antibiotic resistance and persistence. Using bacterial single-cell transcriptomics, we have recognized several
candidate genes encoding the potential regulators for heterogeneous molecular responses under antibiotic
stress. Among these candidates, we will focus on two genes: one that encodes a protein that stabilizes specific
mRNAs, and a second uncharacterized protein that may impact cell-envelope permeability. Over the next five
years, we will employ a synergistic approach of bacterial single-cell transcriptomics and molecular genetics to
rigorously characterize the functions of these candidate genes and their corresponding pathways and uncover
how they mediate heterogeneous bacterial responses under stress. Further application of this innovative
approach over time will build a library of gene targets, thus opening a new direction that will expand our
understanding of bacterial heterogeneity and reveal effective strategies to combat currently hidden bacterial
adaptation mechanisms that threaten to cause treatment failure.

Public health relevance
Project narrative Bacterial heterogeneity under antibiotic stress can result in various cellular outcomes, such as the development of antibiotic resistance and persistence, leading to treatment failure. Our understanding of the mechanisms driving bacterial heterogeneity is currently limited, and there are no markers available for the emergence of bacterial subpopulations that contribute to antibiotic treatment failure. To address this gap, we propose employing innovative bacterial single-cell transcriptomics to study bacterial heterogeneity and identify the underlying genetic regulators that could serve as potential drug targets to prevent antibiotic treatment failure.